Isomerization in cell-to-cell signaling peptides: from discovery to function

Project Summary
In the effort to understand brain function in both healthy and disease states, it is important to identify the active
structures of cell-to-cell signaling neuropeptides and elucidate their cellular signaling pathways. This
information enables the design of therapeutic compounds to modulate these pathways for treating a variety of
human health conditions. Neuropeptides can undergo a subtle post-translational modification (PTM) that
isomerizes one amino acid residue from the L-stereoisomer to the D-stereoisomer. L- to D-residue isomerization
alters the three-dimensional structure of the resulting D-amino acid-containing peptide (DAACP), often leading
to significantly higher biological potency and stability relative to the all-L-residue analogue. A related PTM is
the formation of isoaspartate from aspartate residues to form isoaspartate-containing peptides (IsoAspPs), a
modification that has been implicated in a number of neurological disorders. However, both L- to D-residue
isomerization and isoaspartate formation are difficult to detect because these modifications do not change a
compound’s mass or chemical composition, rendering these PTMs “invisible” to most peptide characterization
approaches. The central hypothesis is that DAACPs and IsoAspPs are present as cell-to-cell signaling
peptides in many animals, including mammals, but have been mischaracterized due to technological
deficiencies in detecting peptide residue isomerization. There is currently an unmet requirement for methods to
detect and predict the occurrence of these functionally important PTMs. This need is addressed with a DAACP
and IsoAspP discovery funnel, a new technology designed to study the synthesis and signaling of peptides that
undergo isomerization, with the long-term objective being to use this information to establish the
neurobiological role these PTMs play in healthy organisms and in neurological disorders. Aim 1 will develop a
non-targeted method to screen for DAACPs and IsoAspPs in a variety of animals and biological tissues. The
method will be used to fully characterize the suite of DAACPs and IsoAspPs present in the central nervous
system of the model organism Aplysia californica, as well as in central nervous, endocrine, and heart tissues of
mouse. Simultaneously, Aim 2 will create a method to identify DAACPs and IsoAspPs at the level of the single
cell using on-slide enzymatic digestion coupled to sensitive single cell mass spectrometry techniques. Finally,
Aim 3 will fully characterize the biosynthesis and signaling of known DAACPs in Aplysia, including identifying
the first L/D-isomerase enzyme that acts on cell-to-cell signaling peptides, which will allow for the identification
of homologous enzymes in other animals, including mammals. Together, these efforts will define the
importance of cell-to-cell signaling DAACPs and IsoAspPs and characterize their synthesis and function
throughout the nervous system. The tools developed will have wide applicability to many future investigations
of cell-to-cell signaling molecules.

Public health relevance
Project Narrative Many neurological diseases are caused by an improper regulation of cell-to-cell signaling molecules, and fully characterizing these signaling molecules and their functions is important to understanding cellular communication in both normal and diseased states. A suite of analytical approaches are being developed to detect and fully characterize peptide signaling molecules that contain two subtle but biologically important modifications, L- to D-residue isomerization and isoaspartate formation. Fully understanding the role of these modifications in neurobiology will provide new insights into brain function, and reveal new diagnostic and therapeutic targets.